Plasmodium ovale hypnozoite development and relapse: a coordinated in vivo in vitro study

ABSTRACT
Malaria control interventions focused on P. falciparum are not adequate to address the growing burden of non-
falciparum species, especially those malaria species that cause relapse. Plasmodium ovale, like P. vivax,
causes recurrent infections arising from hypnozoites in the liver. Hypnozoites “sleeping” in the liver before they
reactivate to cause relapse are invisible to malaria diagnostics and impervious to first-line ACT regimens. Thus
they likely play a key role in the rising number of P. ovale cases across Africa, estimated to exceed 15 million
cases each year. Almost nothing is known about P. ovale hypnozoites and their relapse patterns. We have
only recently learned that P. ovale in fact comprises two non-recombining species - P. ovale curtisi and P.
ovale wallikeri. Interestingly, these two species may exhibit distinct relapse patterns, suggesting species-
specific hypnozoite biology. However, the little evidence available regarding the two species’ relapse patterns
is confusing: epidemiologic data in travelers suggest that P.o. wallikeri relapses occur at shorter intervals, but
the first prospective study of P. ovale in Africa only found relapses due to P.o. curtisi, not wallikeri. We aim to
resolve this question by examining in vivo relapse phenotypes for both species as well as directly measuring
hypnozoite commitment in vitro. We hypothesize that both P. ovale curtisi and wallikeri develop
hypnozoites and relapse in a species-specific manner. To test our hypothesis, we will deploy tools built to
study P. vivax. Using targeted sequencing methods designed to distinguish relapses from re-infections in
endemic settings developed by investigators at the University of North Carolina, and a state-of-the-art 384-well
primary human hepatocyte platform for studying Plasmodium liver stages developed at the University of South
Florida, we will 1) Conduct an observational cohort study to define species-specific relapse rates of P.o. curtisi
and wallikeri and 2) Establish a liver stage model for P. ovale to evaluate hypnozoite commitment in both
species. We will conduct the fieldwork for this proposal within the framework of a larger R01-funded malaria
transmission study in Bagamoyo, Tanzania. This will allow us to leverage the significant molecular and
entomologic capacity we have developed there, where we have already successfully infected Anopheles
gambiae mosquitoes with P.ovale. In partnership with the Muhimbili University of Health and Allied Sciences,
we will identify 40 volunteers with qPCR-positive P. ovale infection, follow them every 2 weeks to genotype any
recurrences that occur over 8-12 months, and conduct mosquito feeding assays to generate 15-20 P. ovale
sporozoite isolates using blood-fed mosquitoes from the same volunteers. Cryopreserved infectious
sporozoites will be shipped to the USF, where liver-stage experiments will be performed to measure
hypnozoite commitment (the ratio of developing schizonts to small-form hypnozoites) and to test anti-
hypnozoite drugs. This study will establish the first liver-stage model of P. ovale. Findings will crucially
inform the development of drugs and strategies to achieve the elimination of all malaria, not just P. falciparum.

Public health relevance
PROJECT NARRATIVE Plasmodium ovale is a neglected tropical disease and an important cause of relapsing malaria in malaria endemic countries worldwide. By studying P. ovale patients in Tanzania we can establish an in vitro liver-stage model to experimentally evaluate the parasite’s liver stages that cause relapse. This work will generate the evidence needed to deploy anti-hypnozoite drugs to help achieve the elimination of all malaria species.